Mitigation of Acute and Chronic Kidney Injuries by Systemic Infusion of Adipose-Derived Soluble Therapeutic Factor Concentrate

ABSTRACT Acute kidney injury (AKI) is a syndrome characterized by rapid loss of the kidney's excretory function. AKI is the leading cause of nephrology consultation and results in 17 million hospital admissions a year. The socioeconomic impact of AKI is significant, resulting in $10 billion cost to the health care system. Despite the high rate of incidence of AKI, no therapy currently exists, other than supportive care. Also, AKI occurs in up to 30% of all patients undergoing cardiac surgery. Despite advances in bypass techniques and intensive care, mortality and morbidity associated with AKI have not changed in the last decade. Furthermore, AKI represents a potential link to chronic kidney disease. Mesenchymal stem cell (MSC) therapies have shown promise in renal disease models; however, there are logistical barriers and potential safety concerns which will limit the usefulness of this therapy. We and others have shown the therapeutic potential of MSC secretome in ischemia/reperfusion (acute) kidney injury models. Here, we propose to assess the therapeutic effect of NFx-101 (our lead therapeutic agent) in the rat kidney ischemia/reperfusion injury model when infused before, immediately after, or 24-hours post injury as well as to evaluate the therapeutic effect of NFx-101 to prevent development of chronic kidney injury in a rat model of high salt induced kidney failure. As a result of this Phase I study we will establish the optimal NFx- 101 dose and regiment of treatment, which then will be used for Phase II study.

Public health relevance
NARRATIVE Acute kidney injury, a syndrome characterized by the rapid loss of the kidney's excretory function, is the leading cause of nephrology consultation, and 17 million hospital admissions a year, resulting in health care costs of $10 billion, and one of the major causes of development of chronic kidney disease. Unfortunately, AKI-specific interventions beyond supportive therapy are currently not available. We propose to develop a therapy based on therapeutic factors produced by stem cells that could potentially benefit the patients with acute kidney injury by reducing the damage of the functional tissue and vasculature of the kidneys.